Kinome-guided Targeting of Cooperative Dependencies in BRAF Mutated Colorectal Cancer

PROJECT SUMMARY / ABSTRACT
Metastatic colorectal cancer (mCRC) is the second leading cause of cancer-related death in the US. Roughly
8% of mCRCs harbor a mutation in BRAF, associated with the worst prognosis and poor response to treatment.
Limitations of standard of care (SOC) therapies targeting BRAF + EGFR include a response rate of 20% and
short time to cancer progression. Results of our original R01 underscore that mCRC is not dominated by
individual oncogenes, rather is mediated by the concerted upregulation of multiple signaling pathways. A key
discovery was a reversible SRC-relayed COX2-inflammatory program that drives resistance to BRAF + EGFR
inhibition (Nature Cancer 2023). Addition of the COX2 inhibitor (COX2i), celecoxib, consistently resulted in more
durable suppression of tumor growth in patient derived xenograft (PDX) models. Furthermore, promising
orthogonal mechanisms of resilience to SOC therapy emerged: a CDK1/2 pathway identified from the
reprogrammed kinome of residual PDX tumors, as well as a BCL-XL driven anti-apoptotic state and a pro-survival
IL8/CXCR2 autocrine loop. With our original R01, we discovered a strategy to improve duration of disease
control; with our R01 Renewal, our translational goals are to manage BRAFV600E mCRC as a chronic disease, to
increase response rate, and trigger tumor cell elimination. Our approach for this proposal is to test the
hypothesis that BRAFV600E mCRC tumors engage a specific set of stress response programs that enable
cancer cells to adapt and survive under therapeutic pressure and represent druggable vulnerabilities. In
Aim 1, we will probe converging phospho-signaling circuits that regulate response to combination therapies
using kinome profiling tools (high-throughput kinase-activity mapping, inhibitor-bead mass spectrometry) and
advanced computational modeling to map the phospho-signaling circuits of banked, residual PDX tumors treated
with SOC ±COX2i ±CDK1/2i. Aim 2 will elucidate core mechanisms of resilience to therapeutic pressure, utilizing
BH3-profiling to define the intracellular mechanisms promoting persistence of tumor cells and identify anti-
apoptotic factors; ELISA and antibody arrays to characterize the autocrine mechanisms that prime BRAFV600E
mCRC to survive drug treatments; and multiplex immuno-fluorescence to quantify the co-expression and
subcellular localization of key, pro-survival proteins in therapy-resistant PDX tumors. The purpose of Aims 1 and
2 is to reveal how therapeutic pressure induces adaptive stress responses that converge on a few critical
signaling hubs, which can be leveraged as drug targets and tested in in vitro models. In Aim 3, we will test
combinations and sequencing strategies with highest clinical potential in PDX models: promising candidates
from our original R01 and additional targets uncovered in Aims 1-2 will be evaluated in therapeutic switch
approaches (i.e., next-line regimen and de-escalation strategy), and new rational combinations including BH3-
mimetic drugs (e.g., BCL-XLi) to induce tumor killing. Our ultimate objective is to meaningfully improve survival
of patients with BRAFV600E mCRC by preventing drug resistance and maximizing therapeutic response.

Public health relevance
PROJECT NARRATIVE Metastatic colorectal cancer harboring a BRAF mutation is associated with poor prognosis and limited treatment options, leading to approximately 75,000 deaths worldwide each year. Building upon our prior success profiling patient-derived tumor samples with an innovative kinase-activity mapping technology, now we seek to identify and target the key stress response programs that enable BRAF mutated colorectal cancer cells to adapt and survive under therapeutic pressure. Our long-term goal is to improve the survival of patients via tailored strategies to prevent drug resistance, restore therapeutic response, or trigger tumor cell elimination.